Longitudinal Immune Dysregulation in Low-Weight Eating Disorders and Association with Weight Fluctuations

Project Summary
The goal of this small grant proposal is to investigate longitudinal changes in inflammatory markers in adolescents
and young adults with low-weight eating disorders (LW-EDs) in relation to (1) weight change and (2) reward
neural circuitry activation. Low-weight eating disorders (LW-EDs); including anorexia nervosa and related
atypical variants, are among the most disabling and fatal psychiatric illnesses, are common in adolescence
(~15%), and often evolve into a chronic condition. Emerging preclinical work supports the involvement of
inflammatory markers in response to starvation and changes in body weight, suggesting inflammatory profiles
may represent a state-specific biomarker demarcating the acute stage of illness. The Our prior epidemiological
work provides evidence of immune dysregulation in LW-EDs compared to healthy-weight controls (HC). More
recently, using a novel proteomic plasma profiling approach, our cross-sectional pilot data demonstrate that
levels of 20 protein inflammation markers distinguish between LW-EDs and HC, suggesting that inflammation in
LW-EDs might be state-dependent. Additional data from pre-clinical studies provides evidence that inflammatory
markers act centrally on regions involved in appetite and reward such as the nucleus accumbens (NAcc) and
hippocampus, indicating pathways through which aberrant inflammatory proteins might impact food intake and
drive weight change in LW-EDs. However, there is a gap in understanding the longitudinal course of inflammation
proteomic profiles in, LW-EDs and relationships between inflammatory profiles and food reward circuitry
functioning in LW-EDs. Our central hypothesis is that aberrant inflammation in LW-EDs (1) represents a state
biomarker driven by weight loss, and (2) is associated with dysregulation in food reward networks (hippocampus,
DLPFC, NAcc, dACC). Among individuals with LW-EDs who gain weight, we predict that disruption in food reward
neural circuitry and inflammation protein profiles will stabilize (anti-inflammatory protein expression levels
increase, and pro-inflammatory levels decrease). Leveraging a recently completed R01 (MH103402) in which
inflammation protein profiles have already been characterized at BL, this secondary data analysis will examine
profiles of 101 female adolescents/young adults (11.1-22.5 years) with LW-EDs (n=61) and HC (n=40) at 9-
month follow-up (9M) using a novel proteomics plasma profiling approach to characterize profiles in stored
serological samples. This will allow for (1) investigation of profiles at 9M, and (2) longitudinal analyses (BL to
9M). Profiles will be investigated in combination with weight change from BL to 9M, clinical characteristics
(including hunger and satiety ratings), and fMRI food cues reactivity data. Age-matched healthy controls will be
used as a negative control group to determine whether changes in inflammatory profiles are specific to the LW-
ED group, rather than random fluctuations over time. This proposal will identify state-specific biomarkers and
therapeutic targets in low-weight eating disorders (LW-EDs), which are notoriously challenging disorders to treat.

Public health relevance
Project Narrative Inflammatory makers have been shown to play a role in low appetite, are sensitive to weight changes, and have been associated with low-weight eating disorders (LW-EDs). However, these effects and the mechanisms through which inflammatory markers are linked to weight change and neural circuitry function have yet to be examined longitudinally in adolescents with LW-EDs. This study will provide insight into inflammation markers, changes over 9 months, and relationships with weight trajectories and neural circuitry functioning in adolescents with LW-EDs, thereby informing the identification of state-related biomarkers and neurobiological pathways to target in the development of treatments for LW-EDs.